A prospective study to support validation of lung deposition models with nuclear medicine imaging methods

Project Summary
In this project we propose to develop and execute protocols for a nuclear imaging deposition study using either
single-photon emission computed tomography (SPECT) or, preferably, positron emission tomography (PET),
with the goal of supporting validation of in-silico models of deposition. These protocols, developed in
collaboration with the FDA, will be optimized to 1) collect data which may be used as input parameters for the
models which use this data for validation purposes and 2) leverage recent advances in SPECT and PET
technology to achieve images with significantly higher spatial and temporal resolution than was previously
possible. Building on approaches developed primarily by researchers Fleming, Montesantos, and Greenblatt, we
will develop methods to derive more accurate estimations of branch-level deposition from the resulting images
by 1) leveraging our experience in quantitative CT segmentation of lung structure, 2) making use of
improvements in image resolution to optimize radiotracer activity localization within airways as small as the 4th
generation, 3) localizing radiotracer activity within anatomic compartments of the lung as small as the segmental
level, and 4) more accurately reflecting disease-specific variations in airway morphology which violate key
assumptions of the work of Fleming and Montesantos.
These protocols will be developed and executed in collaboration with personnel from the Nuclear Medicine and
Radiology and Pharmacology faculty at Erasmus Medical Center as subawardees. These researchers will be
primarily responsible for developing, validating, and implementing a process to produce a radiolabeled
formulation of one orally inhaled drug product (OIDP) which is fit-for-use, as well as appropriate SPECT or PET
protocols optimized for the needs of the overall project. Healthy volunteers and subjects with asthma or COPD
will be recruited from a single center located in Kontich, Belgium. By recruiting subjects with asthma and COPD,
we hope to develop methods which can account for clinically significant differences in ventilation and deposition
which are not accounted for in previous work, specifically emphysema and gas trapping.
The resulting data, including 1) standardized protocols and procedures, 2) images acquired, 3) methods and
code, and 4) results of analysis will be made available to the FDA to disseminate publicly 18 months following
completion of the study, to meet the objective of providing data to facilitate in-silico model validation.

Public health relevance
Project Narrative To facilitate validation of in-silico models of deposition of orally inhaled drug products, we will develop and implement protocols to conduct a deposition study using either PET or SPECT nuclear imaging. By leveraging advances in scanner technology and quantitative CT techniques, we will develop methods to produce more accurate estimates of branch-level deposition from these images than was previously possible. This data will be formatted and shared with FDA to disseminate for use by other groups to validate their in-silico models.